Physiology Core

PROJECT SUMMARY – PHYSIOLOGY CORE
The Physiology Core offers a wide range of services to promote the use of humans and animals in
physiological studies of diabetes. The long-range objectives and goals of this Core are to understand
the pathophysiology of diabetes and its complications. The Core provides advice and hands-on-training
to investigators in clinical studies of non-diabetic and diabetic humans, large-scale analyses of
pancreatic islets, metabolic phenotyping of mice, generation of mouse models of diabetes and obesity,
studies of the role of the microbiome on diabetes and obesity, and use of model organisms such as
Zebrafish and Drosophila in diabetes research. Working with the Cell Biology, Genetics and Genomics,
and Circadian Rhythms Cores, the Physiology Core allows integration of in vitro and in vivo studies of
diabetes.